Understanding addiction vulnerability genes

Addiction vulnerability genes include those that are likely to harbor allelic variants that contribute to human individual differences in vulnerability to addictions. During this and prior years, we identified dozens of candidates to play such roles based on the covergences between nominally-positive data derived from up to fourteen separate abuser/control or quit success comparisons. During the current year we have reported increasing support from outside samples/datasets for the genes that we have identified most consistently in our own data. We added to evidence supporting roles for many of these genes with novel data concerning rate of uptake of developmental use of addictive substances. Genes identified in this fashion include a disproportionate number of genes whose products are involved in cell adhesion molecule actions. During this year we identified additional functional variation at two loci that contain these genes, focusing on extended haplotypes that alters level of expression for CDH13 and PTPRD. These data provide the basis for animal models that replicate, findings in humans and predict stimulant dose-response relationship effects that were recently reported in humans at these two loci. During this year, we reported association between a specific addiction vulnerability phenotype, preference for mentholated cigarettes, and haplotypes in the TRPA1 channel that serves as a menthol receptor in the few African American subjects who prefere nonmentholated cigarettes. D